Role of Task-Specific Context in Sequential Motor Skill learning

PROJECT SUMMARY
One of our brain’s most critical features is its ability for multi-task learning, e.g., allowing us to learn and generate
countless motor skills throughout our lives, from playing the piano to mastering a tennis serve. Since the breadth
of our behavioral repertoire largely depends on this essential ability, disruption of its underlying neural circuitry
has devastating consequences. However, our limited understanding of these circuits and of fundamental
mechanisms of learning and memory in general severely hampers our efforts to develop treatments for diseases
that affect memory like Alzheimer’s or Parkinson’s Disease. In particular, how multiple similar memories are
formed, organized and stored in the same neural substrates remains largely unclear. The relationships between
memories are of critical relevance, since the brain has to continuously balance the separation of memories to
avoid interference with taking advantage of existing knowledge. Here, I propose a multi-level research plan to
investigate the neural mechanisms that enable the brain to achieve this feat. I will use sequential learning of
multiple motor skills as a model for multi-task learning and aim to dissect the underlying neuronal circuits and
mechanisms. I will therefore concentrate on the distributed motor network, which is crucial for learning individual
skills, especially the dorsolateral striatum (DLS) and motor cortex (MC). In addition, I will test how the task-
specific training context influences multi-skill learning. I hypothesize that more similar contexts push sequential
learning towards adaptation of existing skill memories, while less similar contexts promote the development of
distinct skill memories. In Aim 1, I will train rats sequentially on two versions of a motor skill task in which they
develop complex, spatio-temporally precise kinematics. This will allow me to determine the relationship between
sequentially learned skills and how they are influenced by the similarity of their training context. I will address
the same questions on the level of the neural skill representations: I will perform 24/7 electrophysiological
recordings of DLS activity, which represents the kinematics of individually learned skills, throughout multi-skill
learning. In Aim 2, I will test the role of MC in sequential skill learning and whether this role is influenced by the
training context. I will perform the same behavioral and recording experiments as in Aim 1, but I will chronically
silence MC neurons that project to the DLS before learning of the second motor skill. This will reveal whether
MC is necessary to infer context under ambiguous conditions also in sequential skill learning. This multi-level
proposal promises advances toward an understanding of multi-skill learning, how it is influenced by context, and
of memory formation and storage in general. My findings may also provide insights into learning and memory
deficits in motor disorders and help the optimization and development of therapies, e.g., for movement
rehabilitation. Finally, this proposal provides unique training opportunities for the PI in behavioral and
electrophysiological experimentation and data analysis, invaluable skills on the path to independence as a well-
rounded neuroscientist.

Public health relevance
PROJECT NARRATIVE One of our brain’s most critical features is its ability to learn and generate countless motor skills – which is severely affected by injury, stroke or disease, with devastating effects on patients’ daily lives. The goal of my research is to improve our understanding of the neuronal circuits affected in such conditions as well as to elucidate the physiological mechanisms that allow us to continuously learn new motor skills, taking advantage of and not disrupting the skills we have learned before. My findings will not only reveal fundamental aspects of multi-task learning and memory formation, but may also help our understanding of how motor learning may be disrupted and guide the improvement of movement rehabilitation therapies, e.g., by optimizing training schedules for relearning multiple motor skills.